Core B: Biospecimen Processing and Storage

Project Summary – Biospecimen Processing and Storage Core (Core B)
The proposed SPORE will fill an unmet need in cancer health disparities translational research. The Projects
proposed in this application rely on the submission of serial peripheral blood, bone marrow, buccal, and
cerebrospinal fluid (CSF) specimens from children and adolescents with acute lymphoblastic leukemia (ALL)
across the six participating clinical recruitment sites of the REDIAL Consortium. The Biospecimen Processing
and Storage Core (Core B) will serve as the central location where these samples will be processed into the
materials needed for the specific studies associated with Research Projects 1 (treatment-associated
hepatotoxicity), 2 (methotrexate neurotoxicity), 3 (pharmacogenomics), and 4 (patient-reported outcomes,
epigenetics, and social determinants of health), as well as determination of genetic ancestry for use across all
Projects. In addition, the Core will provide biobanking of material that will be available for pilot projects through
the Developmental Research Program (DRP) and Career Enhancement Program (CEP). This Core will support
the collection, shipping, processing, and storage of patient samples from each study site, as well as provide upto-date and accurate sample annotation. The Core will follow previously developed standard operating
procedures to ensure uniform collection and processing for optimal sample yield and quality. The Aims of the
Core are to: 1) Receive and catalog blood, bone marrow, buccal samples, and CSF provided by the Consortium
sites; 2) Process all patient samples to isolate plasma, peripheral blood mononuclear cells, and bone marrow
mononuclear cells, and separate blasts from non-blasts where appropriate; 3) Allocate and distribute samples
to Projects; and 4) Maintain a biobank of samples for future research. The resulting biobank will be an extremely
valuable resource for this U54 translational research grant and future translational studies examining disparities
in childhood ALL.

Public health relevance
Public Health Relevance Core B Biospecimen Processing and Storage Core Latino children with acute lymphoblastic leukemia (ALL) have a higher frequency of treatment-related toxicities compared to other groups. Multiple factors likely contribute to these disparities in this vulnerable population of children, including underlying germline genetics, tumor biology, and social determinants of health. The Biospecimen Processing and Storage Core (Core B) will serve as the central location where biospecimens will be processed and stored to support research that can provide insights into the biological factors underlying cancer health disparities in childhood ALL.